The Oropharyngeal Microbiome in COVID-19

The Oropharyngeal Microbiome in COVID-19
Summary (Abstract)
SARS-CoV-2 first infects the oropharynx and upper respiratory tract, where it either remains localized and is
cleared, or propagates to the lower respiratory tract where it can progress to pneumonia and respiratory failure.
Several patient factors correlate with increased COVID-19 severity, including older age, obesity and diabetes,
but the mechanisms linking these factors to COVID-19 pathogenesis are incompletely understood. What
determines the extent of SARS-CoV-2 upper respiratory tract (URT) replication and whether infection remains
localized or propagates to the lower respiratory tract (LRT) is therefore a critical knowledge gap.
Studies with other respiratory viruses (RSV, influenza) suggest that the local URT microbiome can regulate
immune responses and influence lung consequences of infection. In addition, the SARS-CoV-2 receptor ACE2
is an interferon-stimulated gene, suggesting that it could be modulated by local microbiota. Thus, the microbiome
could play a key role in local SARS-CoV-2 replication and consequences of infection through mechanisms
involving both immune modulation and viral receptor expression. Furthermore, we and others have shown that
the oropharyngeal microbiome is the principal source of lung microbiota, which are derived from the URT by
microaspiration, and so factors that affect the oropharyngeal microbiota likely also impact the lung microbiome
with similar effects.
We investigated hospitalized COVID-19 patients and found that the oropharyngeal (OP) microbiome differed
markedly from healthy subjects and also from hospitalized patients with other illnesses. The OP microbiome at
early sampling points correlated with maximum disease severity over the course of hospitalization. The OP
microbiome also correlated with systemic immune parameters in blood. These findings raise the possibility that
the microbiome in the oropharynx and upper respiratory region may influence severity of COVID-19. However,
there is limited knowledge on the OP microbiome in groups and comorbidities (diabetes, obesity, elderly)
associated with severe COVID-19 disease that might underlie this relationship.
Our hypothesis is that the oropharyngeal microbiome plays a key role in regulating consequences of SARS-
CoV-2 infection through modulation of ACE2 expression and/or immunity that determine whether infection is
locally contained in the URT or propagates to LRT involvement to cause severe disease. This mechanism may
act locally within the URT and also, by URT-LRT microbiome crosstalk, on the LRT. Our aims are to:
(1) Define the oropharyngeal microbiome of individuals at risk of mild vs severe COVID-19, relationship
to expression of ACE2 and relevant mucosal genes, and to microbiome communities seen in early
COVID-19 patients.
(2) Determine the effect of human-derived oropharyngeal microbiome communities, introduced in a
novel murine model, on ACE2 and immune genes in oropharyngeal and lower airway epithelial cells.

Public health relevance
The Oropharyngeal Microbiome in COVID-19 Project Narrative (Summary) SARS-CoV-2 first infects the upper respiratory tract (URT), where it stays localized until cleared or it extends to the lower respiratory tract (LRT) to cause pneumonia, but why infection sometimes stays localized in the URT but sometimes extends to involve the LRT is unknown. Human body surfaces are colonized with microorganisms including bacteria (the Microbiome) that vary with age, disease or other factors and can affect genes and immune function, and we discovered in COVID-19 patients that the URT microbiome was abnormal and correlated with disease severity, suggesting that the URT microbiome may influence progression of COVID-19. In this project we will investigate the URT microbiome in people predisposed to severe COVID-19 (based on age, diabetes, obesity), and use a novel mouse model to determine how it alters URT and LRT genes that are important in SARS-CoV-2 infection.